PREVENTION OF IRON ABSORPTION BY ORAL DEFEROXAMINE &ACTIVATED CHARCOL

The purpose of this study is to determine whether oral deferoxamine/ activated charcoal can decrease absorption of iron when given 30 minutes after ingestion of iron tablets.